GFR MEASUREMENT IN TYPE II DIABETICS WITH MILD IMPAIRMENT

To investigate the glomerular infiltration rate in type ii diabetics using iothalamate clearance determinations as compared to simultaneously collected creatinine clearances.